Kansas Center for Metabolism and Obesity REsearch (KC-MORE) - Metabolism Core

METABOLISM CORE: PROJECT SUMMARY
Metabolism plays a fundamental role in the development of obesity and the pathological consequences of obesity
that lead to chronic disease. Dysregulation of energy balance and impaired storage or oxidation of substrates
are fundamental features of developing obesity and metabolic disease. Metabolic dysregulation is driven by both
alterations in cellular mitochondrial function and disruptions in whole body metabolic homeostasis. Therefore,
metabolic research that connects cellular mitochondrial energetics to whole body in vivo substrate metabolism
and energy expenditure is critical for understanding mechanisms underlying metabolic dysfunction, obesity, and
obesity-related disease states. The Metabolism (MET) core will provide the Kansas Center for Metabolism and
Obesity REsearch (KC-MORE) with expertise, methodologies, and equipment for the study of “metabolism” from
the cell to the whole body. Core missions of the MET core will be to develop a new central MET core facility for
pre-clinical Models (rodents) that provides a host of key measurements, allowing for thorough metabolic
phenotyping. These approaches will include expertise and equipment to quantify real time measures of in-vivo
energy metabolism, substrate metabolism, food intake regulation, and glucose/insulin tolerance testing along
with non-invasive measures of body composition in pre-clinical rodent models (rat and mice). A second core
feature of the MET core will be to provide resources to investigators to quantify mitochondrial energetics in cells
and tissues from both rodent and human samples. Finally, the MET core will also have the capability to perform
metabolic isotope methodologies (isotopic labeled glucose, fatty acids, etc.) for use in humans or rodent models
(in-vivo or ex-vivo) to quantify overall metabolic flux. In summary, the MET core services will be organized to
provide state-of-the art core services to investigators studying metabolism in pre-clinical rodent model systems
and to translational measures of mitochondrial energetics and stable metabolic isotopes for use in cells, tissues,
rodents, and human participants. The MET core is also designed to largely parallel the capabilities of the Human
Energy Balance core so that scientists in the KC-MORE can conduct translational studies in both rodents and
humans.